COMPARISON OF ORAL AND SKIN TEMPERATURE DEVICES IN NEUTROPENIC PATIENTS

Summary of Work: Study Objective: Body temperature measurement is an important aspect of the assessment of neutropenic patients because temperature alterations may indicate critical changes in health status. Monitoring temperature in the traditional fashion is often disruptive to sleep, which is essential to physical and psychological recovery. The purpose of this study is to determine if skin temperature devices are accurate and can be used to monitor trends in body temperature in adult neutropenic patients. Methods: Oral and skin temperatures were simultaneously measured in 25 neutropenic patients every 4 hours for 24 hours. Summary and Findings: Data analysis using Bland-Altman Agreement analysis techniques is in process.